Self-Powered Sample Concentrating and CRISPR-based Biosensing for Moile HIV-1 RNA Detection

Self-Powered Sample Concentrating and CRISPR-based Biosensing for Mobile
HIV-1 RNA Detection
Abstract
HIV/AIDS has become a major public health concern affecting ~37.9 million people worldwide. Early diagnosis
of acute HIV infection during seroconversion window will facilitate early intervention. During antiretroviral
treatment (ART) of HIV-infected patients, it requires frequent monitoring of HIV viral load to confirm treatment
effectiveness, and to identify viral rebound. HIV viral load testing that quantifies HIV viral RNA (circulating HIV
virus) in plasma is the most accurate and reliable approach for the ART monitoring and acute HIV detection.
However, current standard HIV viral load testing methods rely on expensive equipment and well-trained
personnel, limiting their clinical applications in centralized laboratories and hospital environments.
Commercially available immunoassay-based point of care (POC) diagnostic technologies, such as OraQuick®
HIV Self-Test (HIVST), are not effective to detect acute HIV infections, as well as ART failure. As a
consequence, the lack of a simple, rapid, affordable, POC diagnostic tool for HIV RNA detection leaves many
individuals unaware of their condition and impedes timely antiretroviral treatment. To fill this gap, we propose
to develop a low-cost (~ $ 5), rapid (< 35 min), and sensitive (<1,000 copies/mL), clustered regularly
interspaced short palindromic repeats (CRISPR) biosensing platform for HIV viral load testing using finger-
prick volume (~50 µL) of whole blood. In the R61 phase (Aims 1-3), we will: i) develop and optimize highly
sensitive and specific CRISPR biosensing technology for next-generation nucleic acid-based molecular
diagnostics, and ii) design and fabricate a disposable "blood-to-answer", CRISPR biosensing device that
integrates self-powered plasma separation, viral RNA enrichment, and CRISPR biosensing detection. In the
Phase 33 (Aims 4-5), we will systematically evaluate the performance of our integrated CRISPR biosensing
platform, and rigorously validate its feasibility for clinical application by testing HIV clinical samples in the US
and Zambia. If successful, such a simple, rapid, affordable, POC detection platform will enable acute HIV
diagnosis and viral load testing at home and be appropriate for resource-limited settings where HIV is most
prevalent.

Public health relevance
Narrative HIV/AIDS is a global epidemic affecting ~37.9 million people. HIV viral load testing plays a crucial role in HIV patients undergoing therapy, early diagnosis of acute HIV infection, as well as infants born to infected mothers. The objective of this project is to develop a simple, rapid, affordable, CRISPR biosensing platform for HIV viral load self-testing.